Regulation and Manipulation of Innate Immunity During HIV Infection

PROJECT SUMMARY
Innate immune sensing of microbes leads to activation of signal transduction cascades that trigger
multiple transcription factors to rewire gene expression for host defense. However, the mechanisms that regulate
this sophisticated response are not completely understood. This proposal addresses a novel transcriptional
mechanism that regulates the innate response to HIV-1. Our preliminary data define a gene regulatory network
that maps the innate immune response in monocyte-derived dendritic cells, and highlight new transcriptional
circuitry that controls interferon signaling, which is highly relevant for HIV infection. Type I and type III interferon
are known to block acute infection of HIV. However, dysregulated interferon signaling is a hallmark of
pathogenesis and can increase virus replication and spread. Based on our network predictions and experimental
validations, our data indicate that Core-Binding Factor Subunit Beta (CBFb, encoded by the gene CBFB) is a
cell-type specific regulator of interferon and inflammation. Loss-of-function mutations in CBFb have been
associated with breast cancer and acute myeloid leukemia, but a role in regulating antiviral responses through
interferon signaling has not been described. We have found that perturbation of CBFb by CRISPR-Cas9 or RNA
interference leads to spontaneous induction of specific interferon stimulated genes and inflammatory factors in
myeloid cells but not T cells. CBFb is known to be hijacked by HIV-1 Vif in T cells to reduce expression of
APOBEC3 family restriction factors, but our work suggests that CBFb’s impact on HIV is more complex than
previously appreciated. Interestingly, our data indicate that HIV-1 replicates more efficiently in CBFb-depleted
myeloid cells in single-cycle infections, but the virus fails to spread efficiently in replication-competent assays
(and in this case, effects are independent of Vif). The experiments outlined in this proposal will provide a greater
mechanistic understanding of how the transcription cofactor CBFb regulates innate immune responses and
influences HIV-1 replication. With this project we aim to: 1) Determine the mechanism by which CBFb limits IFN
responses in myeloid cells, 2) Determine the direct and indirect targets of CBFb and their impact on HIV infection,
and 3) Validate roles for CBFb during maturation of primary immune cells. By systematically testing mutant CBFb
constructs in rescue experiments, testing the roles of CBFb binding partners (such as RUNX family members),
and testing CBFb-dependent genes that are known to impact HIV replication, we expect to uncover the molecular
mechanism of how CBFb suppresses innate immune signaling and how dysregulation of this function is exploited
during virus infection. Our long-term goals are to understand how cellular parameters can be manipulated to
tune innate responses to HIV-1 and optimize our cell’s antiviral defenses. With this project, we seek to gain
mechanistic insight into the transcriptional regulation of innate immunity, knowledge that could lead to new
treatments to target the virus reservoir and engage anti-HIV immune responses.

Public health relevance
PROJECT NARRATIVE When engaged at the right time and place, activation of the innate immune response can block HIV infection. However, we lack a fundamental understanding of how appropriate innate immune responses are regulated in host cells. This project will use new tools to study the genetic circuitry that regulates innate immune responses and HIV replication, and could lead to innovative therapies that improve anti-HIV immune responses and target the virus reservoir.